A fully implantable speech neuroprosthesis

Loss of communication is one of the most devastating consequences of severe paralysis from a range of disorders, including ALS, stroke, and muscular dystrophy. Recent and ongoing studies have demonstrated the ability to decode words and sentences directly from the neural activity of a paralyzed individual who cannot speak. This success highlights the feasibility of synthesized speech decoded from neural signals using electrocorticography and lays critical groundwork for the development of a fully implantable speech prosthesis. A total implantable device will eliminate physical tethering, reduce infection risk, enable mobile, on-the-go use, expand communication training and capability, and improve patient autonomy and quality of life. Accordingly, we propose to finalize the development of a fully implantable speech prosthesis device system designed to restore real-time communication for patients suffering from severe dysarthria or anarthria. The system features a wireless brain interface device for ECoG recording, digitalization and data streaming and an external portable computer receiving data and hosting real-time speech decoding algorithms. Here, we will complete development and testing of the 3D electronic packaging, the electrode array, and peripherals to enable full integration of the device; undertake device manufacturing and perform functional and safety testing; obtain an FDA IDE; and perform intra-operative clinical studies to optimize the electrode interface and verify critical aspects of device performance. These studies will provide critical groundwork for future chronic implantation trials and subsequent commercialization.

Public health relevance
We propose a neurotechnology development project entailing pre-clinical and human intra-operative testing of a speech neuroprosthetic device intended to benefit patients with paralysis and loss of speech resulting from stroke, amyotrophic lateral sclerosis (ALS) and progressive muscle disorders. This work will pave the way for chronic studies and real-world implementation of speech neuroprosthesis device technology that restores communication and quality of life for affected individuals.